NIDCD Clinical Trials Program (CTP)

The National Institutes of Health (NIH) is seeking to award a service contract to support the National Institute on Deafness and Other Communication Disorders (NIDCD) Clinical Trials Program (CTP) coordination and operations. The contractor will be required to provide specialized expertise in areas such as project management, quality management, and clinical data quality management to directly work with research teams and improve the implementation readiness, quality, and data management of NIDCD-funded high-risk clinical trials. The key objectives are to ensure the quality, rigor, and integrity of NIDCD's clinical trials and build clinical trial research capacity throughout the lifecycle of the trials. Proposals will be evaluated based on technical approach, management approach, corporate experience, and past performance.

Public health relevance
NIDCD is committed to building and expanding our clinical trials program to promote the development of therapies and interventions to treat and prevent communication and other disorders in our core mission areas: hearing, balance, taste, smell, voice, speech, and language. NIDCD has a longstanding history of funding basic science research in these areas and encourages the translation of basic science discoveries to therapies that benefit patients through the conduct of clinical trials and other patient-oriented research.